SINGLE DOSE PK AND SAFETY OF ORAL ADEFOVIR DIPIVOXIL IN HIV INFECTED CHILDREN

This study will test the hypothesis that adefovir dipivoxil will prove to be safe and will meet pharmacokinetic parameters in infants and children with HIV infection.